STUDY TO ASSESS PHARMACOKINETICS OF ESC DOSE OF FAMPRIDINEIN IN MS PATIENTS

The objectives are to assess dose proportionality of sustained release fampridin tablet and to characterize fampridine kinetics in MS patients; to assess the safety and tolerability of fampridine; and to assess, as secondary safety measures, any effects of fampridine on the ECG and/or any observed effects on fampridine pharmacokinetics attributable to concomitant drug therapy.